INSULIN SENSITIVITY AND GLUCOSE EFFECTIVENESS IN OBESE CHILDREN

Comparison of insulin sensitivity, glucose effectiveness, and natural hepatic glucose output in lean and obese children and in obese normotensive and hypertensive children.